Text2QuitPLUS: A Text-based Smoking Cessation Intervention for Sexual and Gender Minority Groups

ABSTRACT
Smoking among sexual and gender minority (SGM) groups, which include lesbian, gay, bisexual, and
transgender (LGBT) individuals, have been reported from different sources as highly prevalent (46% for gay
men and 48% for lesbians). Considering that the smoking rate within SGM groups is more than double that of
the general population (19%) and that smoking accounts
there is an increased risk for SGM individuals to suffer from this fatal condition. Text
effective
at-risk
mobile
for at least 30% of all cancer deaths,
messaging programs are
for smoking cessation and other health behaviors. appealing to traditionally hard-to-reach,
populations who experience barriers to smoking cessation interventions, and who have high rates of
phone and text messaging use, which is the case for SGM users.
it is clear that
They are
Text2Quit is a smoking cessation
intervention that sends tailored, supportive texts to users based on self-selected smoking quit date. Although
this program has been successfully evaluated with the general population in a randomized trial and has been
also tailored to pregnant women, no study has been conducted for evaluating its feasibility specifically among
SGM smokers. This project aims: (1) To develop and evaluate the design of Text2QuitPLUS, an SGM-tailored
version of Text2Quit, through a qualitative approach among 16 SGM adult smokers; (2) To examine
recruitment, retention, and smoking abstinence rates at 1, 3, and 6-month follow-up among 80 SGM smokers
randomized either into the original Text2Quit or the Text2QuitPLUS arm. Engagement with the program will be
also measured bycalculating the number of text message responses for each SGM participant from the
system
records
; (3) To conduct mixed-method research among 32 SGM smokers completing their participation
in the feasibility trial for better understanding study participants' acceptability of the cessation interventions.
Results will contribute to reducing tobacco-related health disparities among SGM groups. Irene Tami-Maury,
D.M.D., M.Sc., Dr.P.H., a Latina scientist appointed as a tenure-track Assistant Professor at The University of
Texas Health Science Center at Houston, is seeking 3 years of support through an NCI K22 Transition
Career
Development for the proposed transition career development plan and research.
To fill critical gaps in her experience, she will obtain specialized training, expert advice, and first-hand
experience in implementing behavioral interventions targeting underserved populations, mHealth, advanced
statistics for analyzing longitudinal data, and mixed methods approaches. She will also expand her knowledge
and skills related to tobacco cessation, SGM health disparities, and research ethics. Dr. Tami-Maury's
comprehensive training and research plans supported by an advisory committee of established researchers in
the field will secure her long-term goal of establishing an independently-funded research program in cancer
prevention and tobacco cessation, with a focus on reducing tobacco-related health disparities for SGM
individuals.
Award to Promote Diversity

Public health relevance
PROJECT NARRATIVE Due to significantly higher prevalence of tobacco use attributed to psychosocial stressors unique to sexual and gender minority groups, implementing targeted and tailored smoking cessation interventions for this vulnerable population is crucial to reduce cancer risk. Phone text risk bisexual, and transgender individuals, who evidence and messaging is appealing to traditionally hard-to-reach, at- populations who experience barriers to smoking cessa tion interventions, particularly to report high rates of mobile phone and text messaging is needed regarding the best text-messaging interventions to support cessation efforts among sexual gender minority smokers lesbian, gay, . Stronger for ultimately reducing the burden of tobacco-related health disparities in this vulnerable group.